Multi-parametric MRI and PET imaging of rat spinal cord injury

PROJECT ABSTRACT
Spinal cord injuries (SCI) initiate a cascade of complex physiological and molecular mechanisms at and around
the site of injury. Beyond the initial damage, secondary and chronic neuropathological effects triggered by
neuroinflammation and molecular changes at the injury site can severely impact spinal cord regeneration. Some
of the mechanisms of interest include glutamate excitotoxicity, demyelination, glial scar formation, toxic free
radical accumulation, and pro-inflammatory cytokine release. These secondary and chronic pathological effects
can severely impede spinal cord regeneration through inhibition of axonal regrowth and progressive cell death
at the injury site. Multi-parametric MRI (mpMRI) provides an array of contrasts sensitive to changes that occur
in SCI. Quantitative magnetization transfer (qMT) imaging characterizes myelin concentration changes through
measurements of immobile macromolecular content. Diffusion tensor imaging (DTI) provides complementary
structural information by evaluating spinal cord axonal tract integrity post-injury. Resting-state functional MRI
(rsfMRI) reports the integrity of gray matter resting state functional networks that are disrupted post-injury.
Chemical exchange saturation transfer (CEST) and Nuclear Overhauser Enhancement (NOE) imaging
generates Z-spectra that reflect changes in the concentrations and/or exchange rates of specific metabolites and
macromolecules, providing high resolution molecular information from the SCI region. In addition, PET imaging
using radiotracers that bind specifically to the translocator protein (TSPO) will provide three-dimensional spatial
maps of neuroinflammatory activity in the injured spine and can validate the interpretation of mpMRI measures.
We hypothesize that using mpMRI, we can detect and quantify relevant structural, functional, and
molecular changes in the spinal cord, longitudinally over time, in a rat injury model, and that imaging
metrics can be used as biomarkers of the effects of therapeutic interventions. These biomarkers will
correlate with animal functional recovery and can be used to evaluate the efficacy of SCI treatments. We
will evaluate the validity of these hypotheses in the proposed study. First, we will optimize and implement CEST
and NOE MR sequence protocols for imaging SCI rats. Next, we will combine mpMRI imaging modalities to
measure the sensitivity of mpMRI for quantifying SCI severity and recovery and for evaluating the efficacy of SCI
treatments, in a treatment study using the neuroprotective drug Riluzole. Finally, we will confirm the structural,
molecular, and behavioral basis of the mpMRI imaging metrics through TSPO PET imaging of
neuroinflammation, motor and somatosensory behavior testing, and histological analysis. The proposed studies
are significant because they will develop, validate, and implement innovative mpMRI methods that can evaluate
and track various neuropathological changes that accompany recovery after SCIs in a clinically relevant animal
model. These methods may then be used to assess novel SCI interventions and treatments, and to provide
comprehensive information on structural, functional, and molecular changes in SCIs over time.

Public health relevance
PROJECT NARRATIVE Spinal cord injuries trigger complex secondary and chronic neuropathological effects, through neuroinflammatory activity and molecular changes at the spinal cord injury site, that can severely affect spinal cord regeneration and recovery. The proposed study will evaluate the use of multi-parametric MRI and PET imaging to characterize structural, functional, and molecular changes in spinal cord injuries over time, and identify biomarkers that relate to spinal cord injury severity and recovery progression. The multi-parametric imaging methods will be applied to evaluate the efficacy of novel spinal cord injury drug treatments and interventions.